Investigation of neural ensembles driving pain chronification

PROJECT SUMMARY
The unpleasantness, or negative affective component, of pain perception is an emotional phenomenon distinct
from the perceptive sensory qualities. This affective dimension of pain underlies the suffering and motivational
deficits of chronic pain patients. However, similar cellular-resolution mechanisms within brain networks is lacking
relative to the intricate nociceptive detail in the peripheral and spinal circuits. Thus, a key step toward accelerating
the development of effective pain treatments must be the discovery of the specific neural circuits in the brain that
are responsible for the aversive and unpleasant quality of pain perception. We recently reported the discovery
and characterization of a basolateral amygdalar (BLA) neural ensemble, at single neuron resolution, that
transforms nociceptive information in affective-motivational behavior in both acute and chronic pain conditions.
While these studies provide a critical point of entry into the complex affective circuits of pain, it is not clear how
the BLA nociceptive ensemble connects with other parts of the larger affective brain circuitry.
Our goal here is to provide a systems-level understanding of the nociceptive cortical brain networks involved in
the affective perception of pain by integrating multimodal data from pain-experience-dependent transcriptomics,
activity based whole-brain circuit tracing, and precision chemogenetic control—anchored in motivational
behavior-based classifications—throughout the transition from acute to chronic pain. Thus, to discover this
nociceptive brain network, in AIM 1 we will use a rabies viral-genetic strategy combined with immediate early
gene mapping in cleared, intact brain tissue to locate key neuronal populations whose activity is altered by
chronic neuropathic pain. In AIM 2, we will employ single-nuclei RNA sequencing to link transcriptomic identity
and change in cellular states during pain chronification in defined nociceptive input cells to the BLA noci-
ensemble. In AIM 3, we will chemogenetically manipulate nociceptive cell-types projecting to the BLA to mitigate
pain affective-motivational behaviors with locally infused microsphere drug-delivery. The cellular and functional
identification of these fundamental nociceptive circuits should open new avenues for developing precision
therapeutics to combat different dimensions of pain experiences, including the unpleasant affective component.
Such circuit-targeted therapies could selectively diminish the suffering of pain patients, regardless of etiology
and without influencing reward, while preserving necessary sensory discriminative processes for protective pain
sensation.

Public health relevance
PROJECT NARRATIVE While chronic pain remains an urgent healthcare issue, our understanding of the brain mechanisms underlying this disease state lack the resolution that has been uncovered for spinal nociceptive circuits. In this application we will use viral-genetic technologies to locate neuronal ensembles that contribute to the process of affective pain chronification. We will then attempt to prevent chronification through targeted modulation of identified ensembles, demonstrating a causative role in the development of chronic pain. The successful completion of these studies will yield new brain targets for the translational development of effective chronic pain treatments that allow patients to still sense pain but without the unpleasant aversion.